Metabolomic Prediction of Pneumonia Severity

PROJECT SUMMARY
Community-acquired pneumonia (CAP) is one of the most prevalent infections in
children resulting in 1.8 million healthcare visits annually. Validated tools to predict severe
clinical outcomes in children with CAP do not exist. The addition of biomarkers to clinical
prediction rules may improve severity prediction, however conventional biomarkers (e.g.
procalcitonin) have limited ability to predict severity in children. We propose identifying novel
biomarkers for pediatric CAP using metabolomics, the study of small molecules. We
hypothesize that metabolites may be better predictors of illness severity as they directly
represent the complex physiological interaction between the environment (e.g. infection) and the
host in a single sample. Preliminary data of urine samples assayed by Nuclear Magnetic
Resonance (NMR) spectrometry, a more specific analytical platform for metabolomics, suggests
amino acids, carnitine and bile acid molecules are important predictors of CAP severity. As a
complimentary approach we will further investigate these classes of metabolites and specific
lipid molecules (i.e. oxylipins) in blood samples using liquid chromatography mass spectrometry
(LC-MS), a more sensitive analytical platform. Information from urine and blood specimens will
generate a comprehensive set of prognostic metabolomic biomarkers as the strengths of both
analytical platforms are being leveraged for this proposal. The targeted approach we propose in
addition to the use of two separate pediatric CAP cohorts, will result in a clinical and
metabolomic biomarker prediction rule to predict severity in children presenting to the
emergency department with CAP.

Public health relevance
PROJECT NARRATIVE Community-acquired pneumonia (CAP) is a common cause of hospitalization in children each year, however there are no validated prediction rules to aide providers in the decision to admit or to predict severity in children more generally. The proposed research aims to identify and validate urinary and blood metabolomic biomarkers predictive of severity in children with CAP presenting to the emergency department using two large pediatric cohorts. The results from this proposal will lead to the development of a multiplex panel of metabolites that can then be assessed prospectively for pediatric CAP.